THE FUNCTION OF CASPASE-8 IN CANCER, ANTI-CANCER IMMUNITY, AND CAR-T CELL FUNCTION

Project Summary/Abstract:
Caspase-8 is the primary protein that drives the extrinsic apoptotic pathway, and is frequently mutated,
contains polymorphisms, or downregulated in various cancers. Through the literature and many previous findings
in our lab, we have identified potential apoptotic and non-apoptotic roles of caspase-8 in modulating T cell killing
and inflammatory signaling. Further, my preliminary data identifies differences in T cell effector markers/function
as well as potential macrophage cytokine signaling. Taken together, these findings implicate Caspase-8 in
interferon responses, macrophage cytokine production, and T cell effector function, all of which have known
importance in anti-cancer immunity. However, despite the downregulation of Caspase-8 in various cancers
and its widespread inflammatory functions in apoptotic and non-apoptotic signaling pathways, its roles
in promoting or inhibiting anticancer immunity or affecting immunotherapies have not been explored.
Thus, the two proposed project aims seek to interrogate the role of Caspase-8 in tumor cells as well as the tumor
microenvironment, with a focus on its potential roles on anticancer immunity and CAR-T cell function.
The goal of Aim 1 seeks to understand the roles of Caspase-8 in cancer cells which influence anti-cancer
immunity. Specifically, this aim will compare relevant murine cancer cells with or without Caspase-8 to identify
differences in (1) proliferation and inflammatory signaling, (2) resistance to CAR-T cell induced killing (3) in vivo
growth and immune cell infiltration.
The goal of Aim 2 seeks to understand the roles of Caspase-8 in the tumor microenvironment (TME),
including immune cells and stromal cells, which influence anticancer immunity. Specifically, this aim will compare
how caspase-8 in the TME alters (1) macrophage polarization, in vivo tumor growth, and immune infiltration, and
(2) ability for CAR-T cells to induce death in relevant murine cancer cells.
The training plan focuses on extending my previous experience in cancer biology and current experience
in the field of cell death into the field of immunology by exposing me to advanced techniques in the field of
immuno-oncology. From presenting at departmental journal clubs, lab meetings, and seminars, to institutional
and international conferences, I will improve my presentation skills. Through a K99 application and manuscript
preparation, I will continue to maintain my writing skills. Finally, through advanced coursework and shadowing, I
will increase my knowledge and experience in the fields of immunotherapies and clinical trials.
The training environment at St. Jude boasts numerous cores which assist with mouse work and gene
editing, while the Immunology department itself boasts flow cytometry and Immunologic Imaging cores
specifically designated for the department. In addition to the many cores, St. Jude hosts numerous symposiums
and provides funding for postdoctoral fellows to receive additional training via courses and conferences.

Public health relevance
Project Narrative: Despite numerous pediatric and adult cancers displaying Caspase-8 mutations, polymorphisms, and downregulation, little is known about how Caspase-8 in the tumor or tumor microenvironment affects anticancer immunity. These studies herein will expand upon preliminary data showing alterations in T cell activation and tumor growth dependent on Caspase-8 signaling by elucidating apoptotic and non-canonical inflammatory roles of Caspase-8 including potential implications for emerging CAR-T cell immunotherapies. Understanding the numerous roles of Caspase-8 in modulating tumor growth, immune response, and CAR-T cell efficacy may help to understand its frequent alteration in human cancers, identify pathways for targeting these Caspase-8-altered tumors directly, and identify therapeutic relevance for current therapies/immunotherapies.